IL-1 ALPHA CYCLOPHOSPHAMIDE IN PATIENTS WITH SOLID TUMORS

The purpose of this study is to assess the biologic effects of Interleukin-1 alpha and, in particular, its effectiveness as a marrow protective agent in patients receiving cyclophosphamide chemotherapy.